Function of TbRIII as a BMP Co-receptor in Human Cancer

While transforming growth factor-β (TGF-β) has a dual tumor suppressor/tumor promoter role in tumorigenesis, the role of other TGF-β superfamily ligands, including the bone morphogenetic proteins (BMPs), is just being defined. TGF-β superfamily ligands utilize a signaling coreceptor, the type III TGF-β receptor (TβRIII), to mediate and regulate ligand binding and signaling through the type I and type II TGF-β superfamily receptors. TβRIII also undergoes ectodomain shedding to produce a natural soluble form of TβRIII (sTβRIII), which we have detected in human plasma. We have recently established that TβRIII also functions as a BMP co-receptor and is required for some BMP-mediated biology, and that TβRIII and BMP have roles in pancreatic cancer EMT and progression. To investigate the mechanism of TβRIII function in human pancreatic cancer the following hypothesis is proposed: BMPs have dichotomous effects on pancreatic cancer progression, with loss of autocrine BMP responsiveness, in part through loss of TβRIII expression and decreased ALK-6 signaling, facilitating cancer initiation and elevated BMP levels, in part through loss of sTβRIII expression, then promoting cancer progression through EMT-mediated increases in cellular motility and invasiveness. This hypothesis will be addressed by four Specific Aims. Specific Aim1: The mechanism by which TβRIII orchestrates the relative bioactivity of TGF-β superfamily ligands in pancreatic cancer will be explored by defining the structural determinants mediating TβRIII ligand binding to BMP, determining the relative ligand binding hierarchy of TGF- β superfamily ligands to TβRIII and sTβRIII, establishing whether sTβRIII serves as an antagonist of BMP signaling and whether the relative expression of TβRIII and sTβRIII regulate the cellular effects of TGF-β superfamily ligands in pancreatic cancer cells. Specific Aim2: The mechanism by which TβRIII selectively increases BMP signaling through ALK-6 will be established by defining whether TβRIII selectively mediates the interaction of ALK-6 with β-arrestin2 to selectively mediate the internalization of ALK-6 and establishing whether TβRIII mediated ALK-3/ALK-6 internalization is necessary for BMP signaling and BMP-mediated biology. Specific Aim3: The levels of cell surface TβRIII, circulating sTβRIII and circulating active TGF-β superfamily members will be established in murine models and human specimens to establish whether these levels are coordinately regulated during pancreatic cancer progression. Specific Aim4: The effect of increasing or decreasing TβRIII and/or sTβRIII expression in murine pancreatic cancer models of initiation and progression will be established to define whether TβRIII and/or sTβRIII have opposing effects on pancreatic cancer initiation and progression. These studies will define the mechanism by which TβRIII orchestrates TGF-β superfamily signaling to regulate the initiation and progression of pancreatic cancer, define the biological implications of TβRIII ectodomain shedding in the context of pancreatic cancer and aid in targeting these pathways for the prevention and treatment of human cancers.

Public health relevance
We have demonstrated that a cell surface receptor for transforming growth factor-β (TGF-β) superfamily ligands, the type III TGF-β receptor (TβRIII), is able to suppress cancer progression in a broad spectrum of human cancers, including cancers of the breast, lung, ovary, pancreas and prostate, by decreasing the ability of the cancer cells to migrate, invade and spread to distant sites. We have also recently established that TβRIII is able to bind and regulate signaling of another subfamily of TGF-β superfamily ligands, the bone morphogenetic proteins (BMPs), and that both TβRIII and BMPs have a role in pancreatic cancer progression. Thus, these studies where we will investigate mechanisms by which TβRIII regulates TGF-β superfamily ligand function in pancreatic cancer are important to perform and relevant to public health as these mechanistic insights will define the biological functions of TβRIII in the context of human pancreatic cancers, increase understanding of the role of TGF-β superfamily signaling and of TβRIII in regulating tumor biology, and aid in targeting TGF-β superfamily signaling pathways for the treatment of cancers and other diseases in which TGF- β superfamily signaling pathways have a prominent role.